Biobehavioral Inflexibility and Risk for Juvenile-Onset Depression

This competing renewal application seeks to conclude a consecutive series of four separately funded
studies, which enabled the gathering of 15+ years of data, on average, on young, depressed patients from
childhood to young adulthood. Our longitudinal developmental data, reflecting multiple domains of functioning,
can yield actionable information about which risk and protective variables/domains best predict clinical and
functional outcomes of juvenile-onset depression (JOD), which is a particularly severe depression phenotype.
Our AIM 1 is to deposit in the National Data Archives (NDA) the data from the first three studies, which will
complement the mandated archiving of data from the most recent (fourth) project. Thereby, these unique data
will be accessible to future analyses by other researchers. Because commonly used modelling approaches
cannot accommodate our questions and the complexity and size of our data base, our AIM 2 is to demonstrate
the novel application of two approaches from the machine learning toolbox (probabilistic graphical models and
ensemble learning methods) to predict JOD outcomes. To enable researchers to fully utilize the data that will
be deposited in the NDA, we will release the Python code packages we develop for AIM 2 as well as the code
for downloading and properly organizing the related information.
The first study, a Program Project started in 2000, included 7- to 14-year-old young patients (probands; n=711)
from 23 mental health facilities across Hungary, whom we diagnosed as having a DSM-IV depressive disorder;
biological siblings of probands (n=301) were also recruited. Portions of the samples were later enrolled in three
consecutive studies, which also included never depressed controls. The most recent project, ended in 2021
when participants were in their mid-20’s to early 30’s, included 308 probands, 229 siblings of probands, and
160 controls. (The reduced sample sizes, compared to prior ones, were due to funding limits). Across the four
projects, close to 1,100 individuals had two or more assessments covering a large array of domains and
variables: key constructs were assessed repeatedly and in multiple ways. To implement AIM 1, our longitudinal
data will be harmonized with NDA structures and definitions and then deposited. To implement AIM 2,
developmentally-framed hypotheses will guide the novel application of machine-learning approaches to JOD
outcomes under two scenarios: for outcomes with a variety of well-known predictors (e.g., recurrent
depression) but scant information about the interrelationships among them and about which are “genuine”
predictors, we will implement probabilistic graphical models; for outcomes the predictors of which are not well
established and/or are supported by equivocal information (e.g., emotion regulation competence in daily life),
we will use ensemble learning methods. The new knowledge we will generate about JOD will have conceptual
implications, will inform efforts to prevent, or mitigate, negative outcomes of JOD, and demonstrate and enable
new ways to fully utilize extensive longitudinal/developmental data sets.

Public health relevance
NARRATIVE. We propose two aims to conclude a series of 4 consecutive, separately funded studies, which enabled the gathering of decades of longitudinal data on young patients with juvenile-onset depression (JOD) from childhood until young adulthood. Aim 1 proposes to preserve and share the data (gathered across the first three studies) on these subjects, their full biological siblings, and controls, by depositing the data in the National Data Archives while Aim 2 involves the novel application of analytic tools from the machine learning toolbox to generate new, development-stage sensitive information about predictors of clinical and functional outcomes of JOD. Our project will preserve and make accessible unique longitudinal data on a particularly severe depression phenotype and yield developmentally informed knowledge about outcome predictors that can facilitate the prevention and treatment of JOD.